Impact of sequence changes on key intrinsically disordered regions of cardiac troponin

Project Summary/Abstract
Cardiac contraction is a tightly regulated process, where the heart needs to generate sufficient power to perfuse
the body during systole and then relax to allow for filling of the ventricles during diastole. Disruption of this
regulation can lead to diseases including cardiomyopathy and heart failure. At the molecular scale, cardiac
muscle contraction is powered by myosin molecular motors pulling on thin filaments consisting of actin, troponin,
and tropomyosin. The troponin complex, comprised of troponins I, T, and C, plays a central role in regulating
contraction by positioning tropomyosin to enable or disable the calcium-dependent interactions between myosin
and thin filaments. Altering the sequence composition of troponin subunits has direct effects on its function, and
point mutations in troponin are prominent causes of cardiomyopathies; however, it is still a major challenge for
the field to connect how changes in sequence affect troponin's functio n. Recent high-resolution structures of
the thin filament revealed critical insights into the structure-function relationship of the troponin complex;
however, there are large, unresolved segments of troponin, which include critical phosphorylation sites and
the locations of many pathogenic mutations. These unresolved yet functionally-significant regions likely
contain intrinsically disordered regions (IDRs) with behaviors that are not well described by traditional
structural approaches. Advances in the study of protein disorder have revealed new paradigms connecting
sequence, disorder, and function, and it clear that sequence changes in IDRs could impact function by
disrupting binding motifs, altering IDR dynamics, tuning conformational biases, introducing new aberrant
interaction sites, and/or affecting interactions with binding partners. Our central hypothesis is that
mutations and key post-translational modifications within troponin's IDRs alter: (1) intramolecular
interactions, (2) intermolecular interactions, or (3) both. Changes in intramolecular interactions will alter
intrinsic IDR conformational biases and/or dynamics, while changes in intermolecular interactions will alter
interactions between troponin subunits and/or the well defined troponin binding partners: calcium,
tropomyosin, actin, myosin. Here, we have assembled a team with expertise in the sequence and simulation
of IDRs (Holehouse), single-molecule structural dynamics of IDRs (Soranno), and cardiac troponin
(Greenberg) that will apply cutting-edge experimental and computational tools to study the connections
between sequence, disorder, and function in key IDRs within troponin. Together, we will test the following
specific hypotheses: (1) Regions predicted to be disordered within troponins T and I are indeed
disordered in isolation and in the context of the thin filament. (2) Both phosphorylation and pathogenic
mutations within troponin IDRs lead to interpretable/predictable changes in the underlying structural
ensemble, conformational dynamics, and/or intermolecular interactions with well-established binding partners,
which in turn alter thin filament activation. (3) Applying integrative tools across scales will enable us to better
predict whether key VUS within IDRs are likely pathogenic or benign. These studies will provide new insights
into the biophysical properties of IDRs and the structure-function relationship in troponin. Moreover, these
studies have the potential to aid in the classification of newly identified variants of unknown
significance found in patients with cardiomyopathy.
.

Public health relevance
Project Narrative Troponin is a key molecule that helps to regulate heart contraction, and mutations in troponin are prominent causes of cardiomyopathies and heart failure. Currently, we do not have a good understanding of how mutations in troponin affect its structure and function, in part, because some important parts of troponin have properties that make them hard to study. We will apply cutting-edge tools to study these parts of troponin, providing new insights into how troponin works and potentially helping physicians better determine which mutations found in patients are likely to cause disease.